Phytochromes: Structural Perspectives on Photoactivation and Signaling

Vierstra, Richard D. PI Phytochromes: Structural Perspectives on Photoactivation and Signaling. GM127892 ? Macromolecular Structure and Function A Study Section (MSFA) PI: Dr. Richard D. Vierstra, Washington University in St. Louis PROJECT SUMMARY The Project Summary is contained in the Research Strategy per NOT-21-030 instructions.

Public health relevance
Vierstra, Richard D. PI PROJECT NARRATIVE Part of the NIH mission is to seek fundamental knowledge about the nature and behavior of living systems, and to apply that knowledge to enhance human health and lengthen life. Our proposed research is relevant to this mission because it seeks to understand how plants and microorganisms, some of which are medically-relevant pathogens, use the phytochrome family of photoreceptors to gather information about their light environment and adjust their growth and development accordingly. In addition, given the widespread biotechnological use of phytochrome variants both as novel fluorophores and as engineered photoswitches, a further understanding of phytochrome structure and photochemistry should accelerate the development of advanced optogenetic tools for tissue imaging and the precise spatial and temporal control of cellular events.